Comprehensive Maps of U1 snRNP Binding to Nascent RNA in Human Cells

PROJECT SUMMARY/ABSTRACT
We propose to develop new methods for the global identification of protein and RNP interactions with nascent
unspliced RNA. We will use these methods to produce comprehensive maps of spliceosomal U1 snRNP binding
across the human transcriptome. U1 functions in pre-mRNA splicing, in the suppression of premature
cleavage/polyadenylation, and in the nuclear retention of RNA. However, information on its binding sites is very
limited, and how these sites differ for the different functions of U1 is not understood. Unspliced introns in nascent
RNA fractionate with the chromatin, and we recently showed that within the chromatin compartment, splicing
factors engage in interactions not seen elsewhere. We developed methods to isolate proteins and RNP’s that
allowed identification of new regulatory proteins interacting with the U2 snRNP, and the isolation of U2-bound
pre-mRNA fragments encompassing the intronic branch points of HEK293 cells. We call this method
fractionation/immunopurification/RNAse protection (FIRP) and find the FIRP maps of U2/pre-mRNA interactions
to be more comprehensive than previous approaches for mapping branchpoints. We now propose to adapt FIRP
to characterizing interactions of the U1 snRNP with pre-mRNA. We will optimize the extraction of material from
chromatin to obtain U1 snRNP complexes bound to pre-mRNA. We will develop new anti-U1 antibodies that
allow 5’ splice site binding analysis across all types of cells. These methods will be applied both to FIRP assays
of U1 snRNP binding and to iCLIP analyses of U1 protein contacts on chromatin-associated RNA. By
characterizing U1 binding sites on a global scale and developing methods for assaying its interactions in different
cells, regulatory environments and genetic backgrounds, we can examine the processes of 5’ splice site
recognition with new breadth and precision.

Public health relevance
PROJECT NARRATIVE We propose to develop new methods for mapping the interactions of the U1 snRNP in human cells that play a key role in the pre-mRNA splicing process, and are essential to the functional expression of genes and often perturbed by mutations causing human disease. An important goal in medical genetics is to identify deleterious sequence variants in patient genomes, but it is currently difficult to predict the effects of many mutations on splicing. By identifying all the binding sites for U1 and assessing their role in splicing and other processes, we will be able to better assess those mutations in patients likely to have pathological effects.